Advancing Science, Practice, Programming and Policyin Research Translation for Children's Environment Health (Asp3ire)

TRANSLATION CORE
PROJECT SUMMARY
The Translation Core of the Oregon State University Center for Advancing Science, Practice, Programming and
Policy in Research Translation for Children’s Environmental Center (ASP3IRE Center) will support and
accelerate the uptake and integration of evidence-based environmental health strategies and programming into
organizations and governmental institutions that reach our families and communities. The overall objective of
the ASP3IRE Translation Core is to expand and accelerate the impact of existing and emerging Children’s
Environmental Health (CEH) research by moving health-promoting and life-saving research findings into
practice. The Translation Core will identify CEH research translation (CEHRT) needs of stakeholders and
match them with best practice materials, strategies & programs to accelerate uptake & adherence of
interventions. It will also connect individuals, community stakeholders, and decision-makers who are
responsible for CEH with university-based researchers, and coordinate training and knowledge sharing to
accelerate the dissemination of evidence-informed CEHRT products. Finally, it will develop, administer, and
support a competitive annual pilot program that will adapt, implement, evaluate and scale proven strategies for
CEHRT products. Specifically, this includes funding 10 pilot grant projects with 1-year timelines. The
Translation Core is well-situated within the ASP3IRE Center and will leverage multi-disciplinary approaches
and expertise to disseminate research findings in diverse communities through effective, evidence-informed
interventions. Our core will work closely with partners and stakeholders (extension, early childhood educators
and CCOs), as well as all cores within the ASP3IRE Center.